Exposure Factors Facility Core

EXPOSURE FACTORS FACILITY CORE: PROJECT SUMMARY/ABSTRACT
The Exposure Factors Core (EFC) provides technical support to Southern California Environmental Health
Sciences Center (SCEHSC) investigators and pilot project awardees to advance environmental health science
research. Led by a complementary pair of environmental and spatial science investigators and in close
collaboration with the SCEHSC Exposure Sciences and Biostatistics & Data Science Methods Research
Programs, the EFC combines exposure assessment expertise from a wide array of disciplines necessary to fully
characterize and understand exposures for population-based research. Services include advice on
environmental sampling design; instrument selection and deployment; field operations and logistics; sampling
protocols; social and built environment data resources; spatiotemporal modeling; remote satellite imagery;
machine learning approaches to data analysis; ecological momentary assessment of real-time exposures and
geographic and psychosocial contexts; assessment of ultraviolet radiation exposure; and a robust assortment of
geospatial analysis platforms. There is a well-defined access and chargeback mechanism for EFC services.
Equipment, consultation, and training are all available across a number of EFC subspecialties. The EFC works
closely with the other SCEHSC Facility Cores to provide guidance on exposure assessment strategies and
approaches for SCEHSC pilot projects, NIEHS and other funded research, and with the Community Engagement
Core to support community partnerships. Effective and efficient methodologies are applied to challenging
research questions. Rigor and reproducibility guide recommendations on exposure study design, instrument
selection, data collection and quality control, and on analysis and modeling of exposure data. The EFC supports
the SCEHSC mission by providing guidance on the latest methodologies, equipment, and exposure assessment
approaches for investigators’ use.